Basic and Clinical Studies in Reinforcing Positive Behaviors in Intellectual and Developmental Disabilities

Project Summary
Understanding complex, comorbid conditions of intellectual developmental disorder (IDD) is an NICHD
priority. Severe problem behavior (e.g., self-injurious behavior, aggression) of children with IDD is prevalent,
potentially dangerous, and negatively impacts social integration and quality of life. Function-based differential-
reinforcement-of-alternative-behavior interventions reduce such behavior effectively, but treatment relapse is
common when a caregiver cannot deliver reinforcement for the alternative behavior. Such relapse is known as
resurgence. Previously, we developed a quantitative theory of resurgence based on two well-established
principles: (1) individuals allocate proportionally more responding to options that produce proportionally more
reinforcement, and (2) the value of past reinforcement decays hyperbolically as time passes. The theory
provides a quantitative account of behavior in dynamically changing reinforcement conditions, including when
all reinforcement ceases (i.e., extinction)—the conditions giving rise to resurgence. In Period 1 of this project,
we showed the quantitative accuracy of many of the theory’s predictions with laboratory animals and we have
shown similar relations in resurgence of severe problem behavior of children with IDD in the clinic. However,
the most important and promising finding from Period 1 was one the theory failed to predict. We found that
exposure to a treatment (i.e., contingency discrimination training, CDT) involving alternating sessions in which
alternative reinforcement was and then was not available during continued extinction of a target response
substantially mitigated resurgence. To account for these effects, we have developed a refined version of the
quantitative theory suggesting that individuals exposed to CDT rapidly learn to discriminate the continued
unavailability of reinforcement for the target behavior, even when reinforcement is not available for the
alternative response, thus serving to inoculating them against later resurgence. These findings and the refined
quantitative theory from Period 1 suggest promising, innovative, and unexplored procedures for treating severe
problem behavior that are likely to produce better resurgence mitigation than existing approaches, while also
avoiding some downsides of the current methods to mitigate resurgence of problem behavior (i.e., arbitrary
stimuli that caregivers may lose or use incorrectly). Period 2 of this project will focus on this highly innovative
approach identified in Period 1 in two aims by conducting: (1) the first randomized controlled trial evaluating the
resurgence-mitigating effects of CDT on severe problem behavior of children with IDD and (2) a series of
experiments with laboratory animals testing the refined theory under a range of conditions predicted to improve
the efficacy, efficiency, and practicality of CDT in future clinical applications. This project represents a close
collaboration between basic and clinical scientists with a demonstrated ability to use basic quantitative
theoretical and empirical research to improve clinical practice to prevent relapse of severe problem behavior,
and thus, to reduce its devastating impact on children and their families.

Public health relevance
Project Narrative Severe problem behavior (e.g., self-injurious behavior, aggression) of children with intellectual developmental disorder is prevalent, potentially dangerous, and negatively impacts social integration and quality of life. Function-based, differential reinforcement of alternative behavior interventions reduce such behavior effectively, but treatment relapse is common when a caregiver does not deliver reinforcement for the alternative behavior. This translational project represents an integrated and unique collaboration between basic and clinical researchers to identify innovative theory-driven methods to reduce such treatment relapse.